Project 4 Gautier

SUMMARY
DNA double-strand break (DSB) repair is essential to prevent persistent DNA damage,
counteract genome instability and suppress tumor development. The spatial organization of
DNA repair is critical to protect the genome from chromosome translocations and complex
rearrangements. Thus, it is critical to better understand the mechanisms underlying the
formation of DNA repair domains and the contribution of these domains to the maintenance of
genome stability and, ultimately, tumor suppression. Armed with novel tools to manipulate the
formation of homology-directed repair domains, we propose three specific aims to assess the
impact of perturbing their formation on DNA repair and genome stability: mutation generation
and chromosome rearrangements. First, we will investigate further how actin movements
generated by the WASP-ARP2/3 pathway participate in DSB repair domain formation using
ARP2/3 inhibition or clinically relevant mutations in WASP. Repair domains will be probed by
state-of-the-art microscopy as well as by chromosome conformation capture assays (Hi-C).
Next, we will assess the consequences of interfering with DNA repair domain formation on
genome stability, specifically on chromosome translocations arising from various genomic
insults: endonucleases, topoisomerase inhibitors and replication stressors. Finally, we will
define the mutational signatures associated with DSB repair domain defects using loss and gain
of function mutations in the WASP-ARP2/3 pathway. This project will greatly benefit from
conceptual and technical interactions with all other projects of the program. The proposed
experiments should provide an unprecedented level of understanding of the impact of the
spatial organization of the nucleus, i.e. repair domains, on genome stability and subsequent
tumor development.

Public health relevance
PROJECT NARRATIVE Aberrant chromosome rearrangements, particularly chromosome translocations, are implicated in the development of human cancers. Chromosomal translocations arise when DNA breaks are inappropriately brought in close vicinity and mis-repaired. Thus, the generation of distinct repair domains is a critical tumor suppressor mechanism. The goals of this project are to determine how DNA double-strand breaks domains are generated to ensure genome stability and how defects in the spatial organization of DSB repair yields specific mutation and chromosome rearrangement signatures.